Synthesis of Sensitive Epitranscriptomically Modified RNAs

Project Summary/Abstract
The objective of this project is to develop a solid phase technology that is universally useful for the synthesis
of epitranscriptomically modified RNAs containing sensitive functional groups. Sensitive functional groups here
refers to those that are unstable under the basic and nucleophilic conditions widely used for deprotection and
cleavage in existing chemical RNA synthesis technologies. Many naturally occurring RNAs including tRNA,
rRNA, mRNA, snRNA, snoRNA, miRNA and lncRNA contain such sensitive groups. They have important
biological functions, and errors related to their installation, reading and erasing are associated with human
diseases. To obtain the knowledge such as the mechanisms by which the sensitive groups modulate RNA
biophysical properties and RNA-protein interactions, and the pathology of diseases involving sensitive groups,
chemical synthesis of the sensitive RNAs are needed. Currently many such RNAs cannot be synthesized by any
existing technologies. The objective of this project is to fill this technology gap. Using a new set of solid phase
synthesis linkers and protecting groups, RNAs will be synthesized, cleaved and deprotected under mild
conditions under which almost all sensitive groups found in living systems so far are stable, and thus the new
technology will be capable to synthesize almost all naturally occurring sensitive RNAs. To illustrate the predicted
broad impact of the sensitive RNA synthesis technology, model mRNAs containing the sensitive ac4C
modification will be synthesized using the technology. Dysregulations of ac4C have been linked to many human
diseases including leukemia, diabetes, obesity and neurodegenerative diseases. Recent studies found that ac4C
in mRNA enhances protein synthesis, but the molecular mechanism is unknown. The ac4C-containing model
mRNAs will be used to fill this knowledge gap. The new knowledge is expected to be useful in areas such as
identification of new therapeutics targets for treating various human diseases, and evaluation of the potential of
ac4C-containing RNAs as medicines. Beyond this specific example, with the access to a wide range of sensitive
RNAs, many other biomedical projects such as the identification of proteins responsible for reading and erasing
various RNA modifications, the use of RNAs containing sensitive modification as training samples for machine
learning in nanopore single molecule RNA sequencing, and deciphering mechanisms by which sensitive groups
regulate RNA degradation and protein synthesis, all of which are impossible or challenging to do at this time,
will become possible for the biomedical research community.

Public health relevance
Project Narrative Many RNAs including mRNA, miRNA, tRNA and rRNA contain sensitive functional groups and thus cannot be synthesized by any known chemical technologies. However, chemical synthesis of these sensitive RNAs is direly needed for many biomedical research projects with aims such as understanding the roles of epitranscriptomic modifications in biological processes, their mechanisms of action, and the pathology of diseases related to them, and the development of RNA-based diagnostic tools and medicines. This project will develop a universal technology capable for the synthesis of a wide range of such sensitive RNAs, and use the technology to synthesize model mRNAs and use them to decipher the mechanisms by which epitranscriptomic modifications regulate protein synthesis.